Using sympathetic nervous system responses to evaluate distressing tinnitus: a pupillometry and skin conductance feasibility study.

Objective. There is no universal measure of tinnitus apart from subjective reports. Therefore, to
improve Veteran health and wellbeing, it is crucial that objective tools be developed that distinguish
between the presence of tinnitus and tinnitus distress. Tinnitus distress is a high impact area of study in
Veterans because tinnitus is consistently the most-common service-connected disability. The Cognitive
Behavioral Model of Tinnitus Distress predicts that one of the proposed mechanisms behind tinnitus
distress is that it increases the cognitive demands on the listener, which interfere with their ability to
concentrate. The application of cognitive resources towards a listening task is commonly referred to as
listening effort. Increased listening effort increases sympathetic nervous system activity, and
pupillometry can reliably capture these changes. The Cognitive Behavioral Model of Tinnitus Distress
asserts that bothersome tinnitus increases arousal and distress, which also increase sympathetic
nervous system activity. Skin conductance measurements reliably increase when participants view or
listen to arousing images and sounds; they also covary with pupil responses. Therefore, this proposal
will use pupillometry and skin conductance to explore how distressing tinnitus alters listening effort and
affective processing.
Design. The proposed study will employ a cross-sectional design and quantify sympathetic nervous
system activity that has been associated with listening effort and affective processing. Adult Veterans
and non-Veterans will be recruited and grouped into one of three categories: 1) adult controls without
hearing loss or distressing tinnitus, 2) adults with hearing loss but not distressing tinnitus, 3) adults with
hearing loss and distressing tinnitus.
Methods. Participants will listen to sentences, view affective images, and listen to affective sounds.
Pupillometry and skin conductance responses will be simultaneously recorded for all stimuli. These
methods will be used to address the following aims:
Aim 1: Quantify the “selective monitoring and attention” component of the Cognitive-Behavioral
Model of Tinnitus Distress by assessing listening effort in Veterans with and without distressing
tinnitus. The working hypothesis is that distressing tinnitus is associated with increased listening effort.
Participants with tinnitus distress will exhibit larger pupil dilations while listening to sentences,
particularly in quiet, compared to adults without tinnitus distress. Skin conductance responses are not
anticipated to be sensitive to listening effort.
Aim 2: Quantify the “arousal and distress” component of the Cognitive-Behavioral Model of
Tinnitus Distress by assessing physiological responses to affective visual and auditory stimuli
in Veterans with and without distressing tinnitus. The working hypothesis is that distressing tinnitus
is associated with amplified physiological responses to affective auditory and visual stimuli. Participants
with tinnitus distress will exhibit larger pupil dilations and covarying skin conductance responses to
affective stimuli compared to adults without tinnitus distress.
The rationale for these aims is that they will lead to the development of high impact tools that will allow
future research to 1) objectively measure therapeutics designed to reduce tinnitus distress and 2)
examine how different comorbidities such as blast exposure, TBI, and PTSD affect tinnitus distress.

Public health relevance
People with tinnitus, or ringing in the ears, frequently report that it impacts their ability to concentrate and can make them feel depressed or anxious. Recently, about 1.5 million adults in the US said that their tinnitus was a “big or very big problem.” Veterans report higher rates of tinnitus than the public, so we expect there to be proportionately more Veterans bothered by their tinnitus. There are no practical ways to measure tinnitus because we cannot pinpoint its location, making it hard to treat. We think that when tinnitus becomes difficult to ignore, people must work harder to listen. We also think that when tinnitus makes people feel depressed or anxious, their bodies respond negatively to certain sounds and pictures. If we are correct, we plan to use these tools to improve how we identify and treat Veterans with bothersome tinnitus.